PS1 mediates the neuroprotective functions of the ephrinB/EphB system

DESCRIPTION (provided by applicant): Excitotoxicity, a form of neuronal damage due to excessive activation of glutamate receptors and oxidative stress are mechanisms of neuronal injury implicated in the pathogenesis of Alzheimer's disease (AD). We found that the ephrinB family of ligand proteins protects primary neuronal cultures from both glutamate- and oxidative stress- induced death. The neuroprotective activities of ephrinB ligands (ephrinBLs) are mediated by their receptors (EphB receptors, EphBRs) and depend on PS1, a protein involved in familial AD (FAD). Interestingly, the neuroprotective effect of ephrinB depends on both PS1 alleles because absence of one allele (haploinsufficiency) results in severe reduction of the ephrinB neuroprotection. Furthermore, we obtained preliminary data that FAD mutants of PS1 interfere with the ephrinB-dependent neuroprotection and that -secretase activity may be involved in the neuroprotective functions of the ephrinBL/EphBR system. Here we propose to further investigate the effects of PS1 FAD mutants and γ-secretase on the neuroprotective function of ephrinBLs and to elucidate molecular mechanisms by which PS1 mediates this function. We will explore whether PS1 regulates the binding of ephrinBLs to EphBRs and the ephrinBL-induced phosphorylation of both EphB and NMDA receptors. To this end we will use cortical primary neuronal cultures from our PS1 knockout and FAD mutant knock-in transgenic mouse colonies as well as EphBR knock-out colonies available in our laboratory. We will also use our mouse models to examine the neuroprotective function of the ephriBL/EphBR system in vivo and to ask whether PS1 FAD mutations affect this function. Finally, we will ask whether PS2, a homologue of PS1 also involved in FAD, may also be involved in the ephrinB neuroprotection. PUBLIC HEALTH RELEVANCE: Excitotoxicity and oxidative stress are neurotoxic mechanisms implicated in the neurodegeneration of Alzheimer's disease (AD). We found that a protein called ephrinB, has neuroprotective functions and rescues neurons from excitotoxic and oxidative death;these neuroprotective effects of ephrinB depend on PS1, a protein involved in AD. Our findings have implications for the mechanisms by which genetic mutations cause neurodegeneration and may provide novel targets for therapeutic intervention in AD.

Public health relevance
Public Health Relevance Statement Excitotoxicity and oxidative stress are neurotoxic mechanisms implicated in the neurodegeneration of Alzheimer's disease (AD). We found that a protein called ephrinB, has neuroprotective functions and rescues neurons from excitotoxic and oxidative death; these neuroprotective effects of ephrinB depend on PS1, a protein involved in AD. Our findings have implications for the mechanisms by which genetic mutations cause neurodegeneration and may provide novel targets for therapeutic intervention in AD.